The Efficacy of CAMP Air, a Web-based Asthma Intervention, Among Urban Adolescents with Uncontrolled Asthma

PROJECT SUMMARY / ABSTRACT
Background and Rationale: Asthma has high prevalence and morbidity among minority adolescents. Yet,
few interventions are tested in adolescents, with only one being web-based. Given asthma's significant impact
on this group, and the important role technology plays in their lives, this oversight is a significant public health
concern. There is a dearth of cost-effectiveness analyses and implementation studies in asthma intervention
research. This study addresses these treatment and methodological gaps. We developed and established the
preliminary impact of the Controlling Asthma Program for Adolescents (CAMP Air), a seven-module
personalized, e-health intervention for adolescents with uncontrolled asthma. Objective: We aim to: (1)
systematically evaluate CAMP Air's efficacy in 370 urban adolescents with uncontrolled asthma; (2) assess its
cost-effectiveness; and (3) identify multi-level factors associated with successful implementation of CAMP Air
to inform its future scale-up. Hypotheses: Relative to controls, over 1-year CAMP Air participants will have
significantly better asthma control as indicated by (a) higher scores on the Asthma Control Test (ACT) and (b)
fewer asthma-related urgent care visits (primary outcomes). CAMP Air participants will also have significantly
better (a) asthma self-care skills, (b) controller medication use, (c) lung function (measured by spirometry),
and (d) quality of life; and significantly lower rates of (e) steroid bursts, (f) symptoms days, (g) nights woken,
(h) activity limitations, and (i) school absences. We hypothesize that compared to the control, CAMP Air will
have favorable value (incremental cost-effectiveness ratio<$100,000/ quality adjusted life years [QALYs]).
Methods: We will enroll 370 9th – 11th graders with uncontrolled asthma from up to 19 NYC high schools. We
will randomize participants to CAMP Air or an asthma education control intervention and follow them for 12
months post-treatment. Using a decision-analytic Markov model, we will estimate CAMP Air's incremental cost
per QALY gained and cost per symptom free days, from both the societal and payer perspectives. For the
process evaluation, which is built on the RE-AIM and Consolidated Framework for Implementation Research
(CFIR) models, we will collect qualitative and quantitative data from students, caregivers, and school
administrators. Together with stakeholders we will develop strategies for widespread implementation of CAMP
Air, informed by our clinical efficacy, cost-effectiveness, and implementation results. Significance: The study
has high public health significance because it (1) targets an understudied population impacted greatly by
asthma, (2) leverages technology in a health disparate population to promote self-care, (3) assesses CAMP
Air's economic value using QALYs and symptom-free days, and (4) bridges a gap between research and
practice by identifying implementation factors to inform strategies for widespread implementation of CAMP Air.

Public health relevance
PROJECT NARRATIVE Despite asthma's high prevalence and morbidity among adolescents, particularly ethnic minority youth, few interventions target this age group. This study will test the efficacy and cost-effectiveness of CAMP Air, a high school-based e-health intervention in urban adolescents with uncontrolled asthma and will examine factors associated with delivery of the intervention. This project has considerable public health relevance because (1) it leverages technology to reduce health disparities, (2) it is delivered in high schools, maximizing the potential for the intervention to be sustained, and (3) it will inform strategies for the widespread implementation of CAMP Air.